Integrated genotype-informed single-cell molecular antibacterial susceptibility testing platform for rapid and actionable diagnosis of bacteremia

Project Summary
Bacteremia, the presence of living bacteria in blood, can lead to life-threatening sepsis and represents a primary
cause of death despite advances in modern medicine. For the diagnosis of bacteremia, the current gold standard
is blood culture. Unfortunately, blood culture is insensitive and can take up to 5 days to complete. During this
lengthy time window, patients may continue receiving ineffective or unnecessary broad-spectrum antimicrobials,
leading to poor treatment outcomes, adverse iatrogenic effects, and increased selection for multi-drug-resistant
“superbugs”. Molecular diagnostics promise to speed up the diagnosis and improve the treatment of bacteremia.
To date, however, such a promise remains unfulfilled because existing molecular diagnostics cannot
simultaneously accomplish: 1) rapid identification of species of the bacteria from a broad panel of potential
causative bacteria, 2) prompt testing of the susceptibilities of the identified bacteria against various antibacterial
agents, and 3) “needs-driven” versatility to adjust test specifications accordant with clinical context. A better
molecular diagnostic platform is therefore urgently needed for the acute management of bacteremia.
In response, we propose to develop an integrated molecular and single-cell detection platform capable of rapid
bacterial detection, species identification (ID), bacterial load quantification, and antibacterial susceptibility testing
(AST) in a streamlined test that allows customizable workflow. First, the proposed platform will perform bacteria
ID and measure bacterial load from blood via ultrafast magnetofluidic PCR and “probe melt analysis” (PMA)
within a magnetofluidic ID device in 30 min. This device is composed of a low-cost cartridge and an automated
instrument. The cartridge and the instrument are designed to perform bacteria lysis, magnetic-based DNA
extraction and purification, and PCR-PMA – a unique strategy that detects each bacterial species by a DNA
probe with a specific melting temperature and fluorescence color code. The species ID and bacterial load
provides guidance and specifications for downstream AST. Next, the proposed platform will conduct “single-cell
molecular AST” to quantitatively detect bacterial ribosomal RNA as a surrogate viability marker at the single cell
level, which has the potential to accelerate testing time to below the time scale of bacteria replication. Single-cell
molecular AST will be performed within a microfluidic chip and a companion instrument that can automate the
assay steps – including antibacterial exposure, bacteria lysis, and single-cell RT-PCR-PMA – in 90 – 150 min.
The proposed molecular detection platform can provide timely and objective data to clinicians during acute care
of bacteremia, which can improve their ability to establish diagnosis and administer antibacterial treatments,
potentially improving clinical outcomes and curtailing the emergence of multi-drug resistant bacteria.

Public health relevance
Project Narrative For early diagnosis of potentially life-threatening bacteremia and combating antibacterial resistance, we propose to develop an integrated molecular and single-cell detection platform that can rapidly identify the causative bacteria and promptly test the susceptibilities of the identified bacteria against various antibacterial agents. Timely diagnosis of bacteremia with the proposed platform can transform acute-care clinicians’ ability to treat patients with appropriate drugs, thus improving treatment outcome and curtailing the emergence of antibacterial resistant bacteria.